Biomedical Informatics, Bioinformatics, and Cyberinfrastructure Enhancement Core

Biomedical Informatics, Bioinformatics, and Cyberinfrastructure Enhancement Project Summary
The Biomedical Informatics, Bioinformatics, and Cyberinfrastructure Enhancement (BIBCE) Core offers a
robust and agile biomedical informatics infrastructure for the Great Plains (GP) IDeA-CTR members with
cutting-edge support tools, expertise and training across bio-, clinical-, and public health informatics realms.
Extensive reliance on genetic and molecular data in clinical practice has become a game-changer in health
care practice, especially, in the emerging field of precision medicine. Hence, clinical and translational research
(CTR) needs a range of supports from data collection and analysis to data integration and correlation to make
clinically relevant inferences effectively. However, it is extremely challenging for individual institutions to locally
develop and maintain sophisticated infrastructure and technical expertise in this rapidly changing field. The
primary objective of the BIBCE Core is to develop such an environment, expertise, tools, and services and
make them accessible across all institutions of the GP IDeA-CTR network. Collecting and connecting data from
the molecular level to population level, the BIBCE Core will provide access to a robust suite of tools for
regional CTR endeavors while building the overall CTR capacity of the GP IDeA-CTR network. While Nebraska
has an extensive telehealth network that links all public educational facilities and hospitals, informatics tools
and expert support are essential to generate multi-institutional collaborations in CTR and having a centrally
supported core will be pivotal to accomplish the mission of GP IDeA-CTR. The BIBCE Core will support this
mission with four specific aims: 1) Augment CTR capacity by leveraging existing infrastructure, networking,
and creative collaborations among GP IDeA-CTR, institutional, and other IDeA-funded projects; 2) Integrate
and streamline access to genomics-based and community health data, biobanks & registries, electronic health
records, and decision support systems across the network to promote translational precision health research;
3) Connect the clinical informatics resources with CTSA’s National Center for Data to Health (CD2H) and other
CTR centers to facilitate easy access and stimulate feasibility studies, outcomes research, and CTR; and 4)
Support data sharing, knowledge and resource sharing, and training using cyberinfrastructure to reach out to
the rural and underserved populations in the GP IDeA-CTR network. The BIBCE Core will have a profound
impact on the success of GP IDeA-CTR through augmenting the overall research capacity in the realms of
clinical, translational, and precision health; bolstering collaborations through team science within as well as
across the IDeA networks; streamlining diverse informatics resources; aligning the regional CTR with national
efforts for interoperability; sharing knowledge with new courses and training activities; and finally, developing
telehealth tools to reach out to the rural and underserved populations.